Circuit and subcellular basis of MDMA effects on innate and learned fear

PROJECT SUMMARY
Methylenedioxy-methamphetamine (MDMA) enhances the extinction of learned threat associations in mice and
humans and has recently demonstrated efficacy in augmenting psychotherapy in posttraumatic stress disorder
(PTSD). However, the mechanism of this effect is unknown. Understanding the neural circuits responsible for
MDMA-enhanced threat extinction may facilitate the development of new treatments of anxiety and trauma-
related disorders. In this application, we utilize longitudinal two-photon imaging of dendritic spines to
characterize the structural changes in frontal cortex occurring with MDMA and how they relate to the 5HT2A
receptor which is both directly and indirectly activated by MDMA. We use microendoscope calcium imaging
and to understand how neural populations in the infralimbic cortex represents innate and learned fear
differently after MDMA treatment. Subsequently, we directly manipulate plasticity optogenetic suppression of
CaMKII signaling affects subsequent innate and learned fear behaviors. Finally, we utilize engram mapping
and optogenetics to stimulate behaviorally specific ensembles of neurons in infralimbic cortex during MDMA
exposure. We hypothesize that activation of distinct ensembles will differentially affect the subsequent lasting
effects of MDMA on behavior. Thus, this study applies cutting edge optical neurophysiology approaches to a
critical mechanistic question: delineating the frontal cortical circuit- and subcellular adaptations to MDMA that
underlie its diverse effects on innate and learned fear.

Public health relevance
PROJECT NARRATIVE Methylenedioxy-methamphetamine (MDMA) releases monoamines and enhances fear extinction learning in mice and humans. Here we employ two-photon imaging to identify structural plasticity that may result from MDMA. Further, we identify shifts in the neural representation of innate and learned fears and its interaction with memory processes within medial prefrontal cortex circuits after MDMA exposure.